Chicago UP on the Environmental Health Sciences

ABSTRACT
Chicago's South and West Sides are urban environmental justice areas facing significant racial and ethnic
disparities in disease risk and outcomes and are in critical need of environmental health research. In 2017, the
“ChicAgo Center for Health and EnvironmenT (CACHET)” was established at UChicago – the first NIEHS P30
Environmental Health Core Center in the Chicago area. As the CACHET membership and projects have grown,
so have prospective training opportunities. As a key CACHET goal is to reduce environmental health related
disparities among residents of Chicago and beyond, it offers the ideal context for encouraging individuals from
diverse backgrounds to pursue careers in environmental health. Multidisciplinary environmental health research
training is offered by clinician, laboratory, and population scientists to understand, evaluate, and ultimately
reduce environmental health related disparities. Research areas of emphasis include air, water, and soil
pollutants, biomarkers of exposure and effect, molecular and cellular processes of toxicity, and a strong
emphasis on community engagement. CACHET offers a robust structure to support training for
underrepresented undergraduates, with extensive research and mentoring opportunities by CACHET
investigators and ongoing research opportunities. Since 2021, we have leveraged CACHET, its EHS faculty
pool, and its research portfolio to support educational activities that encourage individuals from diverse
backgrounds to pursue further studies or careers in EHS research through the Chicago UP on the
Environmental Health Sciences Program (UP on EHS). To accomplish this goal, we: 1) provide 2-year
mentored research experiences and career/skill development to undergraduate students from underrepresented
backgrounds (rising juniors from institutions across Chicago) to inspire and prepare them for further study in the
environmental health sciences; 2) provide opportunities for dissemination in Chicago communities as well as in
academic publications or presentations; and 3) create a strong and long-lasting network of support for students
throughout their career journeys. For each student, we assemble a dedicated mentor team, provide hands-on
research training, and tailor support and projects to trainee needs and interests. We also communicate with
program alumni and offer personalized assistance and encouragement. In the first 4+ years of funding, this has
translated into very positive outcomes for our trainees, illustrating our dedication to preparing students for
graduate school or careers in research. We have proven that our leadership team has the scientific, educational,
and established research programs necessary to ensure the continued success of Chicago UP on EHS. We plan
to continue engaging cohorts of diverse or underrepresented undergraduates in this renewal application and
build upon the strong NIEHS P30 research/researcher infrastructure and ideal context for the NIEHS
Undergraduate Research Education Program (UP) to Enhance Diversity in the Environmental Health Sciences.

Public health relevance
PROJECT NARRATIVE UP on EHS at UChicago has leveraged the robust scientific, educational, and mentoring infrastructure offered by NIEHS-funded P30 ChicAgo Center for Health and EnvironmenT (CACHET) to offer research training and career development to undergraduate students from backgrounds historically underrepresented in the environmental health sciences. Through innovative partnerships with CACHET members, didactic instruction/preparation, community-based work, ongoing seminars, and tailored support from UP on EHS leadership, our students have successfully transitioned to graduate school and work in research. We plan to build upon the success of the first 4+ years for this renewal application and continue to engage and train cohorts of students who will be inspired and motivated by the CACHET dedication to disparities mitigation, environmental justice, and close connection with impacted Chicago communities.